Cardiopulmonary Exercise MRI in Heart Failure with Preserved Ejection Fraction

Project Summary
Cardiovascular disease (CVD) is the leading cause of morbidity and mortality in the United States, with the
prevalence of heart failure with preserved ejection fraction (HFpEF) rising every year. Currently, there is no single
non-invasive diagnostic test for accurate diagnosis of HFpEF. HFpEF is diagnosed through a combination of
symptom assessments, plasma biomarkers, and cardiac imaging. When patients are acutely decompensated,
HFpEF can be diagnosed with high confidence. However, among stable outpatients presenting with dyspnea on
exertion and an intermediate pre-test probability of HFpEF, diagnosis is extremely challenging. Since non-
invasive testing has limited diagnostic specificity, in these cases, invasive hemodynamic cardiopulmonary
exercise testing (iCPET) is considered the gold standard. However, iCPET is invasive, carries risk, and is
performed only in specialized centers. Cardiovascular MRI (CMR) can non-invasively assess HF-related heart
and vascular abnormalities including biventricular structure/function, myocardial tissue composition, coronary
microvascular function, aortic distensibility/stiffness, and fat accumulation. As cardiovascular and pulmonary
symptoms of HFpEF occur with exertion, the objective of this proposal is to use a supine ergometer mounted on
the MRI scanner table to examine heart and lung pathophysiology with exercise of incrementally increasing
resistance, followed by a conventional vasodilator stress imaging protocol. The goal of this study is to use our
novel cardiopulmonary exercise MRI protocol to accurately diagnose “early” HFpEF, to eliminate the need for
iCPET, and to identify specific pathophysiologies underlying HFpEF progression and prognostic information for
adverse CVD outcomes. To achieve this, we will recruit patients from three medical centers to conduct a
prospective study using cardiopulmonary exercise MRI in suspected “early” HFpEF patients who are clinically
referred for iCPET, with a follow-up MRI scan 18 months later. Our three specific aims seek to 1) Investigate
non-invasive imaging correlates and diagnostic performance of cardiopulmonary MRI for early HFpEF diagnosis
in patients with normal ejection fraction and unexplained dyspnea, using iCPET as a reference standard; 2)
Investigate the relationship between cardiopulmonary exercise MRI parameters and CVD health outcomes,
including cardiovascular death and hospitalization in suspected early HFpEF; 3) Explore temporal changes in
heart and lung structure and function in suspected early HFpEF by completing a second cardiopulmonary
exercise MRI 18 months after the initial MRI exam. This innovative cardiopulmonary exercise MRI protocol is
expected to improve non-invasive diagnosis and prognosis of HFpEF, and ultimately contribute to improved
treatment strategies and preventative care by providing more accurate diagnostic criteria and a non-invasive
method of monitoring the efficacy of new treatment strategies in clinical trials.

Public health relevance
Project Narrative Heart failure with preserved ejection fraction (HFpEF) is an increasingly common cardiovascular disease that significantly impairs physical abilities and has a poor long-term survival. As HFpEF is challenging to diagnose non-invasively and has no effective treatment strategies, this study seeks to use a novel cardiopulmonary exercise MRI protocol, involving supine ergometry, to accurately diagnose early stages of HFpEF and identify specific markers to better understand HFpEF progression and predict adverse cardiovascular health outcomes. The information gained from this study will improve diagnosis and prognosis for patients with HFpEF and eliminate the need for invasive hemodynamic cardiopulmonary exercise testing (iCPET), which is the current more costly, risky, and invasive diagnostic testing method.